COMPUTATIONAL FACILITY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Resource's computational facility provides the necessary computational resources utilized by Resource scientists. The facility offers Resource researchers and collaborators tools such as large local disk storage for their files and research data, various computational machines and clusters for simulation and data analysis, and advanced visualization workstations and projection facilities featuring 3D stereoscopic visualization and imaging. This facility saw many improvements over the past year (http://www.ks.uiuc.edu/Development/Computers/).